Immunologic and Neurodevelopmental Consequences of Neonatal Anemia and Thrombocytopenia and their Treatments

SUMMARY
The Administrative and Data Management Core (Core A) will be based at Boston Children's Hospital, and will
be directed by Dr. Sola-Visner. Core A will provide administrative, communication, and data management
support to all four projects within the PPG and to Core B. Administratively, Core A will be responsible for the
management of the overall budget, the establishment of subcontracts with the different sites, and all
communications with NIH, including the preparation and submission of progress reports. Core A will also
facilitate the communication among members of the PPG, including the organization of monthly meetings, ad-
hoc phone or web-based video conferencing, the annual site review visit, and a yearly project leader meeting.
Another critical function of Core A will be to establish a state-of-the-art central Data Management System that
will support remote data collection, centralized storage, sharing of data, and generation of datasets ready for
statistical analysis and mathematical modeling. The support provided by Core A in these areas will be central
to the functioning of the PPG and is essential to its success.